THIRD ANNUAL SO NEW ENGLAND PALLIATIVE CARE CONFERENCE

DESCRIPTION (Applicant's Description) The Third Annual Southern New England Palliative Care Conference is designed for an interdisciplinary mix of professionals interested in acquiring, maintaining and/or expanding knowledge and skills in the delivery of palliative care. It aims to present state of the art content in key areas of palliative care: pain management, grief and bereavement, ethics and economics, and interdisciplinary collaboration. Workshops provide a rich selection of critical issues in adult and pediatric populations. Dr. Hebert Benson, a nationally recognized physician-speaker, will focus on stress management for the professional caregiver.